Piezo1- Mediated Type H Vessel Formation in Periodontitis

Project Summary/Abstract
Periodontitis is defined as an inflammatory bone lytic disease of which onset and progression is associated with
the host immune responses to the dysbiosis of periodontal microbiome. Type H vessels characterized by the cell
surface markers, CD31 and endomucin (EMCN), have been found in bone tissue as microvascular structures
that is specialized in the induction and maintenance of osteogenesis. Piezo1, a mechanosensitive receptor
expressed on endothelial cells (ECs) play relevant regulatory roles in development, growth and function of ECs.
The preliminary results showed that the number of Type H vessels in alveolar bone diminished in periodontitis
compared to that in periodontally healthy alveolar bone, and that activation of Piezo1 expressed on EC can
promote the polarization of ECs toward Type H phenotypes. The EMCN expressed on ECs was reported to
interrupt the leukocyte’s trans-EC migration. Based on these lines of evidence and preliminary results, it is
hypothesized that activation of Piezo1 expressed in vascular ECs induces polarization of type H vessels which,
in turn, down-regulate the infiltration of osteoclast precursors from blood circulation to the bone surface of
alveolar bone in periodontitis. This hypothesis will be tested by the following two Specific Aims: Aim 1) To
demonstrate that the stimulation of Piezo1 expressed on vascular ECs can polarize them towards type
H vessels. Aim 2) To determine the role of Piezo1 expressed on ECs in the type-H vessel formation using
a mouse periodontitis. Major four training goals in the career development plan include: 1) Gain and improve
expertise in basic scientific methods associated with osteo-vascular biology, osteoimmunology and
periodontology, 2) Obtain skills in management and analyses of datasets, 3) Acquire technical methods to
conduct proposed K08 research strategy, and 4) Develop competencies required to lead a research program,
including participation of grant writing course and workshop. Mentor, Dr. Han, and co-mentor, Dr. Kawai, Dr. Du
and Dr. Crane who are experienced in the proposed study addressing the periodontal osteoimmunology,
microfluidics or type H vascular biology, as well as mentoring of postdoctoral fellows and junior faculties for their
career development in the academic research fields, will be committed to support the candidate’s career
development, along with consultation committees composed of 3 expert researchers in the fields of pathological
immune dysregulation related to the leukocyte migration, 3D transparent tissue histology, and Piezo1-mediated
mechanosensory system, respectively. All required equipment, devices, protocols and materials are available in
the laboratories of mentors and consultants. The candidate is given a desk and laboratory space in Center for
Collaborative Research (CCR) which is the largest biomedical research building in South Florida, equipped with
a variety of cutting-edge equipment in the core facilities, all of which are available for the candidate’s research
project. The successful completion of this potentially paradigm shifting project in periodontal research is expected
to form the foundation for a future RO1 grant application.

Public health relevance
Project Narrative This study is proposed to determine the role of recently identified subset of endothelial cells, i.e., type H vessel, in the induction and maintenance of osteogenesis in the alveolar bone affected by periodontitis. Since bone regeneration in the alveolar bone defect caused by periodontitis has been major challenge in the periodontitis research and none of the study has ever addressed the coupling between angiogenesis and osteogenesis, this study is anticipated to cause a paradigm shift in the field. Outcomes from this project will be translated into a novel therapeutic approach not only to prevent pathogenic bone resorption, but also to induce bone regeneration in periodontitis.